Abberior Infinity Line Upright 3D STED/Confocal Microscope

Abstract:
The Department of Otolaryngology has active research across all of its divisions. The
department has run a core facility for over 12 years that is accessible to more than 100
researchers within our department. The core facility is a training facility that fosters
collaboration across technical expertise and biological questions. We are requesting the
purchase of a super- resolution imaging system that will be placed into this core facility
where training, scheduling and maintenance can be managed by experienced staff. The
Abberior STED system incorporates the most up-to-date technology to provide the most
versatile super- resolution system available. The use of adaptive optics and adaptive
illumination allows for high-resolution live cell imaging. The incorporation of avalanche
diodes provides the most sensitive detectors available. Quad scanners maintain beam
positioning and alignment while providing image rotation. Matrix array spectral detection
offers the next generation of improved signal to noise by removing out focus light. STED
FLIM allows for lower power laser to improve live-cell imaging. It further provides optical
colocalization by using a single light path for multiple emissions. Multiple emissions are
possible by separating fluorophores by lifetime rather than wavelength. There are no
existing systems at Stanford so this new device will be critical for many scientists both
within and outside of our department. Work within our department spans from basic
science to translational to clinical. It ranges from cancer to aging, to neurological
disorders, sensory integration and drug and diagnostic development. It is directly in line
with the mission of NIH in terms of a primary focus on health-related research and training
of the next-generation of scientists. Our core facility also serves as a training facility where
we engage students, postdocs, residents, etc. and train them on the first principles of the
technology development, experimental design and data analysis. Finally, the Department
of Otolaryngology supports the core facility and will support this new addition by providing
the space and the resources needed for staff as well as maintenance, service and
oversight of the equipment.

Public health relevance
Narrative: We are requesting a super resolution STED Microscope from Abberior. The super resolution nature of this system will enable users to generate a more detailed localization of the key molecular and morphological features necessary for inner ear development, function and regeneration. This system accommodates both live cell and fixed tissue imaging.